Signaling and Metabolic Regulation of Nucleotide Metabolism and Cell Growth

PROJECT SUMMARY
Nucleotides serve as pivotal bioenergetic molecules vital for diverse cellular processes, encompassing RNA and
DNA synthesis, glycosylation, phospholipid metabolism, energy production, signaling, and cytoskeleton function.
During the past decade, my independent research has led to fundamental insights into the molecular
mechanisms that govern the metabolic pathways, enabling cells to grow and proliferate. My laboratory has made
significant discoveries by molecularly connecting the pro-proliferative signaling pathways to nucleotide
metabolism. We have achieved landmark discoveries by precisely delineating the molecular regulation of de
novo purine synthesis downstream of the ERK signaling pathway, elucidating the effects of mTORC1 signaling
on the methionine cycle and RNA methylation, and demonstrating the pivotal role of environmental bicarbonate
in fueling de novo nucleotide synthesis in response to mTORC1 activation. Recently, our findings have not only
expanded our understanding of metabolic function but also reshaped the biochemical landscape. We have
overturned conventional wisdom by revealing the indispensable role of pyrimidine nucleotides in supporting
vitamin B1 metabolism and mitochondrial pyruvate oxidation and Krebs cycle function. These revelations hold
profound implications, not only for our comprehension of metabolic physiology but also for the development of
innovative drug strategies. The success of our efforts has been underpinned by the support of two NIGMS-
funded R01 grants, serving as the lifeblood of our research pursuits. My lab has thrived in answering fundamental
questions regarding cellular metabolism regulation and uncovering novel metabolic functions for purine and
pyrimidine nucleotides. This proposal embodies the ethos of the MIRA funding scheme, empowering researchers
to pursue ambitious science and delve into higher-risk endeavors. Through MIRA funding, we aim to uncover
metabolic connections between the nucleotide synthesis pathways and metabolites, identify the molecular
mechanisms of nucleotide sensing in human cells, and expand the horizons of our research endeavors. The
stability and flexibility inherent in MIRA funding will enable us to propel scientific discovery forward, forging new
knowledge in the realm of signaling and cellular metabolism and advancing our quest for innovations.

Public health relevance
PROJECT NARRATIVE Understanding how cells sense available nutrients and subsequently orchestrate crucial decisions governing growth, proliferation, and differentiation represents a fundamental yet enigmatic aspect of cellular biology. Building on our recent discoveries, this proposal aims to determine how cellular nucleotides are timely sensed and how metabolites contribute to the control of nucleotide metabolism. Ultimately, these findings may offer novel avenues for targeting signaling and metabolic pathways implicated in various human diseases.